Administrative Core

The Administrative Core is the nexus for coordination among the projects, including management of personnel and budgets, as well as organization of meetings and workshops and dissemination of research to share methodological and theoretical developments and empirical findings. The Administrative Core is charged with both internal and external liaison and integration. It coordinates interaction among the program's projects and between the program and other research on aging. It is responsible for administrative coordination with the NIH/NIA and with the various universities and centers associated with the program. Two Working Groups will be organized and managed in the Administrative Core.

Public health relevance
Is it true that males are healthier than females but die younger? If so, why? This Core supports research projects that address these questions concerning the human health-survival paradox. Findings will provide a deeper understanding of the basis for sex differences in health and survival -- and of the opportunities that society and particularly health professionals have to improve health and survival for males and females.